Regulation of MicroRNA Populations by Oncogenic Viruses

Project Summary
MicroRNAs (miRNAs) are small non-coding RNAs (ncRNAs) that post-transcriptionally regulate gene
expression of more than half of human messenger RNAs (mRNAs); aberrant miRNA levels are linked to
disease, including cancer. miRNAs associate with Argonaute (Ago) proteins and guide them to complementary
sequences on mRNAs resulting either in mRNA suppression upon partial base-paring, or in Ago2-mediated
mRNA cleavage when perfect base-pairing occurs. Recently Dr. Steitz’s group and others discovered yet
another outcome of miRNA base-pairing for three herpesviral RNAs that exhibit extensive, yet imperfect,
complementarity to host miRNAs, and result in degradation of the miRNAs. This process, of a still
uncharacterized mechanism, is known as target-induced miRNA degradation (TIMD) and the miRNA-binding
site is called the miRNA-degradation element (miR-DE). For example, HSUR1 – a ncRNA encoded by
Herpesvirus saimiri (HVS) binds to and mediates decay of host miR-27a. miR-27a is a repressor of T-cell
activation and its decreased levels contribute to HVS-induced lymphomas. Importantly, while the biogenesis of
miRNAs has been extensively studied, their turnover is poorly understood. The presence of miR-DE-containing
viral RNAs alone is sufficient to induce miRNA decay, suggesting that TIMD is an undescribed cellular miRNA
decay mechanism. In addition, other known herpesviral miR-DEs reside in mRNAs, implying the existence of
analogous elements in other viral and human transcripts. In this study, I intend to delineate the novel
miRNA degradation machinery (Aim 1), as well as to identify yet unknown transcripts derived from
oncogenic viruses and their hosts that induce miRNA decay (Aim 2). In the K99 phase, I will identify TIMD
intermediates by adapting TimeLapse – a method developed in the lab of our collaborator Dr. Matthew Simon
that assesses RNA turnover using single time point high-throughput sequencing. I will gain insight into TIMD
mechanism by obtaining a crystal structure of Ago2-miR-27a-HSUR1 complexes in collaboration with Dr. Ian
MacRae. I will validate predicted miR-DEs encoded by oncogenic Epstein-Barr virus that target tumor
suppressor miRNAs (miR-150 and miR-125b) by analyzing their ability to induce miRNA decay in B cells. I will
construct a fluorescent protein-based reporter responding to changes in miRNA levels to perform a loss-of-
function genetic screen to identify cellular enzymes participating in TIMD. In the R00 phase, I will characterize
the candidates for TIMD obtained in the genetic screen. I will search for additional RNA motifs necessary for
miR-DE function by using bioinformatics and mutagenesis. I will then use a refined bioinformatic pipeline to
search for human miR-DEs. This study will delineate the miRNA turnover mechanism, which could be linked to
disease, and will bioinformatically identify potentially oncogenic viral and human transcripts. The Pathway to
Independence Award will allow me to gain necessary expertise (i.e. in bioinformatics) and professional skills
(i.e. in teaching, writing) to become a competitive candidate for an academic position at a top-tier university.

Public health relevance
Project Narrative Recent identification of three herpesviral transcripts that selectively induce degradation of host microRNAs will enable delineation of a yet unclear cellular microRNA decay machinery. Discovery of additional viral transcripts with microRNA decay-inducing properties will advance knowledge of how human herpesviruses induce cancers and will contribute to development of new diagnostic and therapeutic approaches.